Commensal resilience mechanisms in the inflamed intestine

PROJECT SUMMARY
The human gut microbiota is increasingly recognized as having essential functions in human health. However,
the microbiota is constantly subjected to challenges such as intestinal inflammation, which drives the microbiota
into a perturbed state that can exacerbate diseases. Therefore, microbial resilience, which maintains the
structural and functional stabilities of the gut microbiome in the face of perturbations, is critical to host health.
The overarching goal of our research program is to elucidate the molecular mechanisms that govern commensal
resilience in the inflamed intestine. During intestinal inflammation, host processes known as nutritional immunity
starve gut microbes from essential micronutrients such as iron. In contrast to the well-studied strategies that
pathogens employ to overcome host nutritional immunity, little is known about how gut commensals survive iron
starvation in the inflamed gut. The primary goal of our research program for the next five years is to define
the resilience mechanisms that maintain commensal iron homeostasis during gut inflammation. Enteric
pathogens overcome nutritional immunity by producing iron-chelating molecules termed siderophores. Here, we
show that the model gut commensal Bacteroides thetaiotaomicron (B. theta) acquires iron in the inflamed gut by
pirating siderophores from an enteric pathogen that causes intestinal iron limitation. Notably, B. theta captures
siderophores using a unique system absent in other Gram-negative bacteria. However, such a capture
mechanism can be exploited by enteric pathogens to “re-pirate” siderophores from gut commensals to evade
nutritional immunity. In addition to increasing iron uptake, we show that B. theta employs small, non-coding RNAs
to orchestrate iron conservation and maintain intracellular iron homeostasis in the inflamed intestine. With this
MIRA award, we will define commensal resilience mechanisms by addressing two related but independent
questions in fundamental bacterial physiology: 1) How does xenosiderophore acquisition mediate B. theta
resilience during gut inflammation? 2) How does B. theta manage intracellular iron homeostasis in the inflamed
intestine? We will approach these questions using an interdisciplinary pipeline consisting of cutting-edge omics
experiments, bacterial & host genetics, and a mechanistic understanding of bacterial physiology in vivo. The
completion of these research projects will reveal the mechanisms by which gut commensals adapt to iron
limitation in the inflamed gut and how such adaptation shapes the structural and functional stability of the gut
microbiome. The proposed work is innovative because it adds commensal iron metabolism as a previously
unappreciated dimension to the intricate interactions between pathogen and nutritional immunity. This work is
impactful because it will provide much-needed insights into how interphylum iron metabolism contributes to gut
microbiota resilience in the inflamed gut.

Public health relevance
PROJECT NARRATIVE A marked decrease in essential micronutrients such as iron perturbs the gut microbial community during intestinal inflammation, depleting beneficial commensals. Despite being central to maintaining the overall microbiota structure and functions in the face of perturbations, the mechanisms underlying commensal resilience remain poorly understood. By elucidating the mechanisms of how the prevalent gut bacterium Bacteroides thetaiotaomicron survives iron starvation in the inflamed gut, we will advance our knowledge of both fundamental bacterial physiology principles and resilience mechanisms of the gut microbiota.